Data Core

Project Summary
The Database Management and Statistical (DMS) Core of the Columbia Alzheimer’s Disease Research Center
formalizes and expands central data management and biostatistical resources and functions that have existed
since the inception of the Columbia ADRC in 1989. The specific aims of the DMS Core are as follows:
Aim #1: Maintain a central data resource for information generated by all cores and provide well-defined
procedures and mechanisms for maintaining the accuracy, integrity and security of Columbia ADRC data.
Aim #2: Facilitate access to Center resources, including clinical, genetics, biofluids, neuropathological, and
imaging data.
Aim #3: Ensure timely submission of data to NACC and work with the Administrative Core to facilitate and
coordinate data sharing, including the processing and fulfillment of requests for data and biological resources.
Aim #4: Serve as a resource to the other cores and Alzheimer’s research initiatives with respect to research
design, statistical analysis, planning and training.
Aim #5: In collaboration with the ORE and Clinical Cores, enhance existing web-based systems to a) support
recruitment into clinical trials and observational studies; b) facilitate inclusion of NIH-designated high-risk
populations in the ADRC and related projects; c) streamline acquisition and submission of autopsy data.
By centralizing data management, epidemiological and statistical oversight and training in the DMS Core, we
will ensure consistency in data definitions, sample selection, epidemiologic considerations, choice of statistical
tests, model building and interpretation of study results.